A Spatial and Temporal Analysis of MCH Signaling in the Developing Adipocyte

Project Summary/Abstract
Melanin-concentrating hormone (MCH) helps control human sleep, appetite and energy
expenditure, anxiety, and mood. Localization of its receptor, MCHR1, to primary cilia
seems critical of its physiological role because both ciliopathies and short cilia correlate
with the obese phenotype. We’ve shown that MCHR1 also localizes to a transient
primary cilium during differentiation of 3T3-L1 adipocytes, and that MCH signaling is
changed while the receptor is in the cilium. This transient, ciliary-localization behavior
of MCHR1 is not seen in most neuronal cells expressing the receptor, and it creates a
useful model system for studying signaling inside and outside of the ciliary environment.
Our central hypothesis is that MCHR1 signaling is adaptable to its cellular
microenvironment, intersecting with different signaling pathways as the tissue develops
to control adipogenesis. Furthermore, we predict that the release of pro-inflammatory
cytokines from adipose tissue is enhanced by MCH, but only during specific
developmental stages of adipocyte differentiation. In Aim 1, we will decipher MCH-
derived signaling pathways targeting actin filament rearrangements by testing the
hypothesis that MCHR1 migration into primary cilia reverses how MCH signals to the
actin cytoskeleton using a collection of simple assays to study signaling to Arf6/ARNO,
RhoA, MKL1 and G/F-actin pool ratios. In Aim 2, we will elucidate the spatial and/or
interactome differences regulating MCHR1 signaling in primary cilia by exploring G
protein bias, β-arrestin recruitment patterns and co-localization with potential signaling
partners. Finally, In Aim 3, we will explore the role of MCH in building and maintaining
an adipose tissue infrastructure by determining how MCH influences several
immunoregulatory genes during adipocyte differentiation and we’ll test MCH-induced
3T3-L1 secretions for macrophage recruitment and biofilm formation. The proposal is
significant is it designed to engage undergraduate and master’s students in a mentored
research environment, but also addresses important questions about the impact of
subcellular localization on G protein-coupled receptor signaling within the context of
obesity.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Project Narrative: This project will expand our understanding of how adipose tissue expansion and maturation is impacted by an appetite-stimulating hormone, MCH, potentially revealing new drug targets for the treatment of obesity. The spatial role that a tiny primary cilium has in mediating the effects of MCH will be investigated, as well as gene expression changes that happen in response to MCH as the tissue matures.